Deep Immunophenotyping in tissue imaging

PROJECT SUMMARY
There is a growing demand for deep phenotyping of single cells in tissue, giving rise to the field of spatial biology.
High multiplex imaging technologies such as cyclic immunofluorescence and mass spectrometry imaging are
poised to transform spatial biology and pathology workflows. However, these technologies are limited by their
cost, complexity, and long sample-to-result time. Iterative fluorescence approaches are limited to 3–6-plex per
round of staining, imaging, and de-staining, while mass spectrometry imaging can provide ~50 plex but with
lower throughput and much higher costs. This proposal’s objective is to address these bottlenecks by significantly
expanding fluorescence spectral multiplexing in tissue imaging—the maximum number of protein markers per
fluorescence imaging cycle—from 3–6 plex to 56 plex, by developing a new type of ultrabright semiconducting
polymer dot (Pdot) with simultaneously narrow absorption and emission bands.
We will accomplish this objective via the following aims: (1) Develop a 56-color panel of Pdots with
simultaneously narrow absorption and emission bands; (2) Demonstrate 56-plex imaging applied to immune
profiling of cells in tissue samples and evaluate performance; (3) Demonstrate even higher multiplex imaging
(168 plex) via cyclic imaging (with only 3 cycles) for extremely deep cell immuno-phenotyping, useful in clinical
discovery and research applications.
The narrow-absorption Pdots will be immediately applicable as they can be used with existing commercial
instruments. These Pdots will also enable spectral imaging—a new technology inspired by spectral flow
cytometry, in which the full spectrum of dye emission is collected to better distinguish dyes and facilitate higher
multiplexing. The proposed project is significant because it addresses the need for detecting tens to hundreds
of protein markers in tissue samples in a simple, timely, and affordable manner.

Public health relevance
PUBLIC HEALTH NARRATIVE There is a growing demand in personalized medicine to measure many biomarkers in a single sample. In tissue imaging, high multiplexing is essential for identifying different cell types and states in complex systems such as the immune microenvironment. This project will significantly expand spectral multiplexing in tissue imaging of proteins markers—the maximum number of target proteins measurable in a single round of immunostaining and fluorescence imaging—from 3–6-plex to 56-plex, thus enabling deep immuno-phenotyping of cells in tissue samples.